ADMINISTRATIVE CORE

The Administrative Core Unit A will be a resource to all other projects in the Program Project. The Administrative Core will monitor and dispense all funds and will maintain an accurate accounting system for the various projects and core unit. It will also coordinate activities such as seminars, weekly research meetings and visits by advisors and other investigators.